AUTOMATED INFORMATION EXTRACTION FROM MEDICAL IMAGES

The use of image processing techniques for extraction of clinically important information from medical images is proposed. Since at least one application of image processing, white blood cell differential counting, is in widespread use, it seems likely that further research will lead to additional applications of image processing in clinical medicine. Also, many medical images are now digital and thus already contain quantitative information which, if analyzed, could result in significant improvements over manual interpretation. Scene segmentation, or getting the computer to locate objects of interest within an image, is one of the key problems in computer aided image interpretation. The lack of an automated scene segmentation technique makes the practical clinical application of a quantitative image analysis technique virtually impossible, since the regions of interest must be outlined manually, a tedious process at best. It is proposed to develop, for the first time, a systematic methodology for solving scene segmentation problems. This will be done through the use of an objective scene segmentation error measure as feedback to assist in the development of improved segmentation techniques. Images from Pap smear specimens will be used as the prototype for this methodology, which will then be used to develop segmentation procedures for echocardiograms and radionuclide thallium scans. Successful application of this algorithm development method to several areas would validate its generality. The availability of a systematic approach to the development of scene segmenttion algorithms would allow more widespread application of quantitative image analysis. This has the potential for improving medical care by providing clinicians with heretofore unavailable quantitative information.